Retinoic acid signaling in decidualization

PROJECT SUMMARY/ABSTRACT
Human infertility is a global problem and failure of embryo implantation accounts for a significant
percentage of pregnancy failure during both natural pregnancy and in vitro fertilization procedures.
Implantation is an extremely complicated process requiring precisely controlled hormone signaling,
growth factor signaling, and cell-cell interactions. Decidualization is a required step in the implantation
process. It involves the rapid proliferation and differentiation of fibroblast-like endometrial stromal cells
into epitheloid-like decidual cells. These cells become part of the decidual tissue that surrounds the
implanting conceptus. Decidualization defects can directly lead to implantation failure. Moreover, early
decidualization defects can cause other adverse pregnancy outcomes including abnormal placentation,
restricted intrauterine fetal growth, and early parturition. Understanding decidualization is crucial for
improving IVF success rates, developing novel contraceptives, and discovering new treatments for
endometriosis. Despite its significance in reproduction, the genetic framework of decidualization had
never been systematically studied until our recent development of a suitable high throughput screening
tool, immortalized human endometrial stromal cells that carry the yellow fluorescent protein gene under
the control of the progesterone-sensitive prolactin promoter (PRL-Y cells). We recently used PRL-Y
cells to perform a whole genome siRNA functional screen to uncover novel regulatory genes for human
decidualization. One major signaling pathway uncovered by the screen is the retinoic acid (RA)
signaling pathway. Contrary to the current dogma that RA suppresses decidualization, we propose a
paradigm-shifting hypothesis that RA signaling is absolutely required to initiate and promote
decidualization, and is therefore required for female fertility. In this proposal, we will follow up on our
exciting preliminary findings and study the function of RA signaling during decidualization through
careful mapping of its downstream signaling pathways. In Aim I we will determine which RAR or
combination of RARs is required during decidualization, and we will clarify the tissue-specific
requirements for RA signaling during peri-implantation. In Aim II, we will identify RA downstream targets
during decidualization in mouse and human. Finally in Aim III, we will investigate the interplay between
RA and FGF signaling, and between RA and homeodomain proteins during decidualization. Successful
completion of this project will dramatically increase our understanding of RA signaling during
implantation/decidualization and will have an enduring impact on implantation biology and drug
discovery.

Public health relevance
PROJECT NARRATIVE This project proposes to study the function of retinoic acid signaling in embryo implantation and uterine decidualization. Unveiling of retinoic acid receptor regulated genes during decidualization will dramatically increase our understanding of its function during this process. Results from this study will have a lasting impact on implantation biology and drug discovery.